BMY-27857 (2'3'-DIDEHYDRO-3'-DEOXYTHYMIDINE, D4T) ADMINISTERED TO HIV+ PATIENTS

Study objectives are to determine the safety of oral doses of BMY-27857 (D4T) administered three times a day to patients with symptomatic HIV infection, to establish pharmacokinetic parameters for D4T.